Discipline: Two - Track: 2

Project Summary DB/T2 Chemistry: Human Food Product Testing The purpose of this analytical track is to improve food testing surveillance programs through the chemical analysis of food products. The test results generated by these laboratories can be used to remove adulterated food from commerce and aide regulatory inspection programs in conducting investigations. WI BLS is opting out in years 1 and 2 of this grant, and then in year 3 -5 plan to test Juices for Mycotoxins, foods for allergens, and a variety of vegetables for pesticides, fungicides, and herbicide.